A generative-AI-assisted platform for rapidly creating interactive,accurate 3D explainers for all of biomedical science and medicine

Project Summary / Abstract
Making biomedical science and medicine comprehensible at all learning levels is critical for fostering the next
generation of scientists. For high impact learning in science, technology, engineering, and mathematics (STEM),
particularly in formal educational settings, doing so requires excellent learning resources and teachers, and there
is unfortunately a strong demographic and geographic bias in terms of access to these resources. Recently,
there has been an explosion in students’ use of generative artificial intelligence (AI) chatbots as a primary
information source. These nearly zero-friction web applications convey the possibility of free, high-quality
educational resources. These tools, however, are generally exclusively text-based responses that are plagued
by inaccuracies.
We propose to develop a visually-driven generative AI platform that empowers users by generating
interactive, 3D visual explainers with accompanying narration in response to simple text prompts. This caters to
a wider range of learning styles, particularly those who benefit from visual elements. To guarantee scientific
accuracy and visually faithful representations, Snorkle Labs leverages a robust system of expert-vetted data.
We plan to establish a comprehensive reviewer recruitment pipeline to ensure the scientific integrity of the
platform's content. Additionally, real-time, interactive features like controllable camera angles and zooming
capabilities will contribute to a dynamic learning experience, allowing users to delve deeper into specific details
within the 3D models and datasets.
This Phase I project focuses on developing a beta version tailored to the NGSS-aligned high-school
biology curriculum. We will also prioritize establishing a framework for "guardrails" to ensure scientific accuracy
through a rigorous expert review process and meticulous data traceability protocols. Looking towards a Phase II
project, we envision broader user deployment across various educational levels, a flourishing network of expert
reviewers, and the integration of advanced scientific simulations and functionalities. Ultimately, Snorkle Labs
holds immense potential to revolutionize the landscape of biomedical science and medical education by
providing an engaging, user-friendly platform that delivers visually stunning and scientifically accurate
information.

Public health relevance
Project Narrative Students at all levels are increasingly using generative artificial intelligence (AI) chatbots such as OpenAI’s ChatGPT as a primary information source. However, these tools are error-prone and largely limited to text-based responses that can lack context and background if not expertly prompted. We propose to create an entirely new, visually driven generative-AI web platform for all of science and medicine that offers the user interface simplicity of a simple text prompt yet generates an interactive visual output that can rival research-driven, museum-caliber content. The proposed product will convert a text-based input to a fully interactive visual tour including narration, curated data, and camera motion.